Administrative Core

The Administrative Core will coordinate the activities of the individual projects with the Morphology/Cell Culture Core and the Mouse Core, and will be the interface between the Program Project and the Grants and Contracts Office at Washington University School of Medicine, visitors and advisors to the program, and the Division of Lung Diseases, NHLBI. Agendas for the bi-monthly meetings of the project leaders will be arranged by the Administrative Core and administrative decisions taken at these meetings will be implemented by this core. The Administrative Core will handle payments for investigators' travel, expenses associated with publications, service contracts and repairs for shared equipment. The Administrative Core will develop the agendas for visitors and assist them with travel arrangements. The Administrative Core will prepare reports for institutional review committees and progress reports for the NIH.